Differential Diagnosis in Learning Disabilities

PROJECT SUMMARY
On February 4, 2022, NICHD released a Notice of Intent to Publish a Funding Opportunity Announcement for
Learning Disabilities Research Centers (NOT-HS-22-001). The CLDRC plans to respond to this anticipated
RFA to continue its research on learning disabilities and related disorders into years 31-35 under a new award.
This notice indicated that the earliest estimated start date for successful applications will be July 1, 2023. The
funding period for our current award ends on July 31, 2022 (the end of Year 30 for our Center), meaning that
there will be an 11-month gap between the end of the current funding period and the earliest potential start
date for a new award if our renewal application is selected for funding.
One of the greatest strengths of the Colorado Learning Disabilities Research Center (CLDRC) is the
infrastructure that has been developed and sustained over the past 30 years to support the research, clinical,
mentorship, and dissemination efforts of the CLDRC. The current application requests supplemental funds to
ensure that we are able to sustain this critical infrastructure during the gap in funding between the end of the
current funding period and the earliest potential start date according to the Notice of Intent to Publish (NOT-
HS-22-001). Specifically, the supplemental funds will (1) support the retention of two senior research faculty
who will otherwise be forced to discontinue their effort on the Center, (2) facilitate the retention of three critical
staff members who have over 55 collective years of experience coordinating all of the activities of our Center,
and (3) ensure that we are able to continue to provide funding for three current graduate mentees. As
described in more detail in this application, the ability to retain these individuals is critical to facilitate the
successful completion of the stated aims in our funded application despite the unexpected delays that occurred
due to COVID-19 during the current funding period.
If the Administrative Supplement is approved, all funds will be expended in ways that are consistent with the
specific aims approved during the last competitive review of the CLDRC. If our application for competitive
renewal is unsuccessful or there is not a new funding opportunity, the Administrative Supplement funds will be
used to facilitate the timely closure of our Center, including the completion of all projects and the development,
documentation, and release of deidentified datasets for use by qualified investigators outside our Center.

Public health relevance
PROJECT NARRATIVE The NICHD recently released a Notice of Intent to Publish a Funding Opportunity Announcement for Learning Disabilities Research Centers (NOT-HS-22-001). The CLDRC plans to respond to this anticipated RFA to continue its research on learning disabilities and related disorders. The current application requests supplemental funds to allow the CLDRC to sustain critical infrastructure and complete all current objectives during the gap between the end of the current funding period and the earliest potential start date if a new RFA is released and our application for competitive renewal is successful.